DRP Core: Developmental Research Program

Developmental Research Program (DRP) Project Summary/Abstract
As mandated by NCI SPORE Guidelines, the University of Texas Special Program of Research Excellence
(SPORE) has a Developmental Research Program (DRP). The SPORE DRP is funded by a combination of
NCI SPORE grant support ($50,000 direct costs), and institutional support from UTSW and UTMDACC
($150,000 direct costs) for a total budget of $200,000. With average awards of $25,000, this funding permits
~8 DRP Awards per year. The Specific Aims of the DRP are: 1. Provide Funding for Developmental
Research Projects; 2. Use expertise of members of the SPORE External and Internal Scientific Advisory
Boards, and Senior Executive Committee to identify high-impact projects with potential lung cancer clinical
translational utility; 3. Build on the existing well-structured SPORE mentorship platform for Development
Research Projects; 4. Build on the existing framework for direct communication between basic and clinical
scientists, within and outside UTSW and UTMADCC, across disciplines, and training and guidance of a new
generation of translational lung cancer researchers; 5. Facilitate development and transition of these
successful projects into competitive applications for extramural peer-reviewed funding; 6. Build on the existing
well-structured SPORE DRP to ensure that scientific advances are translated into the clinic to benefit patients
with lung cancer. The overall DRP goal(s) is to fund UTSW, MDACC personnel, and extra-institutional
candidates with MD or PhD degrees at all academic levels who want to pursue a career in lung cancer
research and who have prepared an application with high potential for significant impact on lung cancer
pathogenesis, diagnosis, prevention, prognosis, or therapy. As part of this effort, awardees will have access to
Lung Cancer SPORE Core resources (such as preclinical models, Molecular Pathology, Data Sciences), and
access to mentorship by experienced lung cancer investigators and patient advocates. DRP Awardees will
bring new and innovative ideas and approaches to lung cancer translational research, and be trained in
identifying major lung cancer problems to attack, as well as new approaches, concepts, technologies, data
gathering and analyses for understanding lung cancer biology, pathogenesis, diagnosis and therapy. The DRP
is run by the SPORE MPIs from UTSW and MDACC (Minna, Gerber, Roth, Heymach). Applications are scored
by the SPORE External Advisory Board (EAB) based on the applicant’s ability, significance of the project,
innovation, approach, research Environment, and potential of project. Special efforts are made to recruit
women and minority applicants. Over the 20 year history of this SPORE, the DRP has been highly successful,
with a large number of awards leading to important publications, providing preliminary data for other grants,
assisting with faculty promotions, and progression of DRP recipients to major roles in SPORE Projects and
Cores.

Public health relevance
Developmental Research Program (DRP) Project Narrative Project Narrative The Lung Cancer SPORE Developmental Research Program (DRP) provides pilot project funding for lung cancer projects, prepared by early career or established faculty investigators with the potential for clinical translation with significant impact on the diagnosis, prevention, or treatment of lung cancer. With this funding comes access to SPORE Core Pathology and Data Sciences Resources and mentorship by experienced lung cancer investigators and patient advocates. These pilot Developmental Research Program projects should lead to publications, applications for other grant funding, and as appropriate, clinical trial development, and advancement as part of the overall SPORE Program.